Harnessing Communication Preferences to Enhance Its Persistence and Mitigate Relapse of Challenging Behavior

PROJECT SUMMARY/ABSTRACT
Individuals with intellectual and developmental disabilities (IDD) often exhibit behavior that poses a
risk to themselves (e.g., self-injurious behavior), others (e.g., aggression), or their environment (e.g., property
destruction). These challenges can limit their ability to participate in meaningful social, educational, and
vocational activities. The aims of the current project are to demonstrate an approach to a behavioral
intervention (functional communication training [FCT]) to (1) promote long-term maintenance and resilience
in the face of disruption and (2) evaluate its relation to response and participant variables. FCT is the most
widely researched behavioral treatment to address challenging behavior exhibited by individuals with
developmental disabilities. This treatment involves teaching appropriate communication to replace challenging
behavior as a way of recruiting reinforcers. For example, teaching an individual to use a speech generating
device to request parent attention instead of engaging in inappropriate attention-seeking behavior (e.g.,
aggression). Its efficacy has been demonstrated in hundreds of published studies, but it remains important
clinically to develop treatment components that influence treatment maintenance when FCT encounters
disruptions (e.g., communication “no longer works” or new contexts are encountered). Treatment maintenance
includes both (1) enhancing persistence of appropriate communication and (2) reducing relapse of challenging
behavior. Recent research suggests that designing FCT based on an individual’s preferred communication
modality (a) reduces challenging behavior, (b) teaches an appropriate communicative response, (c) increases
the persistence of the functional communicative response (FCR), and (d) reduces relapse of challenging
behavior. However, the existing literature surrounding preference of communication modality is composed of a
small number of investigations employing single-case experimental designs. While promising, these examples
lack demonstration that communication-modality preference improves treatment maintenance in the context
of a randomized controlled trial, considered the gold-standard for intervention research. The proposed study
will intentionally compare FCT that incorporates an individuals’ preferred communication modality (PrefFCT)
to FCT that incorporates an equally successful communication modality, but one that is less preferred
(NonPrefFCT). Treatment maintenance will be compared across both modalities (PrefFCT and NonPrefFCT) in
a randomized controlled trial by two relevant outcomes: (a) the persistence of the FCR and (b) relapse of
challenging behavior, when disrupting treatment with both reductions in reinforcer rate and
context/implementer changes. Quantifying effectiveness of preference modality with an RCT will contribute to
enhancing dissemination and adoption of this approach by practitioners. The outcomes of the proposed
research will contribute to enhanced quality of life for individuals with IDD by optimizing FCT to improve
communication and reduce challenging behavior.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the treatment of severe challenging behavior exhibited by individuals with intellectual and developmental disabilities (IDD). The outcomes of the studies will provide information how to best design communication-based interventions that are resilient in the face of treatment disruptions. These outcomes will contribute to improved quality of life for individuals with IDD through the identification of optimally effective behavioral interventions to improve communication and reduce challenging behavior.